Role of HADHA in regulating right ventricular mitochondrial structure and energetic function in pulmonary hypertension

Pulmonary hypertension (PH) is associated with poor prognosis that is determined by right ventricular (RV)
function. No RV targeted therapies are available and the underlying mechanisms of RV dysfunction in PH remain
unclear. Thus, there is an unmet need to understand cellular and molecular mechanisms associated with RV
dysfunction and to convert this knowledge into therapies. Cardiomyocytes determine RV function in PH.
Mitochondria through oxidative phosphorylation (OXPHOS) are the major source of energy in the heart.
Targeting RV mitochondrial health, bioenergetics and function in settings of PH may provide novel therapeutic
strategies to improve RV function in PH. Cardiolipin, a critical lipid unique to the mitochondria, is important for
mitochondrial structure and function. Respiratory complexes in the mitochondrial electron transport chain play a
critical role in OXPHOS and generation of reactive oxygen species. Our preliminary data demonstrates a
decrease in mature cardiolipin content and complex I proteins and function in dysfunctional RV that correlates
with a decrease in expression of alpha subunit of trifunctional protein HADHA. We hypothesize that reduced
expression of HADHA results in impaired cardiolipin maturation, complex I, mitochondrial structure, and
myocardial energetics that collectively causes RV dysfunction and failure. We will test this hypothesis by
determining the underlying mechanism of reduced mature cardiolipin and impaired complex I expression and
assembly in dysfunctional RV and determining the resulting consequences on subcellar, cellular, and organ
function. In addition, we will test if restoring HADHA expression in vivo will result in improved RV mitochondrial
structure/function, metabolism, and function in settings of PH. The proposed studies are expected to further our
understanding into role of HADHA in RV dysfunction and identify new therapeutic opportunities to target
myocardial mitochondrial function and energetics.

Public health relevance
Pulmonary hypertension is a disease where there is narrowing of the blood vessels in the lungs causing the dysfunction and failure in the right side of heart, which is associated with poor prognosis. This proposed study will investigate the reasons that underlie the weakening of the right side of heart with a focus on mechanisms responsible for energy generation in the heart muscle. Should the experiments be successful, we will discover a new way to increase energy generation in the heart muscle in the right side of heart and thereby improve the heart function and outcomes in Veterans suffering from pulmonary hypertension.